Ovarian function and hepatic mitochondrial quality control in steatosis

Project Summary/Abstract
Hepatic steatosis (fatty liver) increases the risk for liver disease and type 2 diabetes, major health issues for
Veterans. Reduced hepatic mitochondrial function (MitoFX), defined as reduced mitochondrial -respiration and -
fat oxidation, increased H202 emission, and uncoupled mitochondria, contribute to hepatic steatosis and liver
injury. In contrast, exercise protects against steatosis/liver injury via improving or enhancing MitoFX. Female
mice and women are protected against steatosis compared to males. Still, their susceptibility to steatosis and
poor metabolic health dramatically increases after the loss of ovarian function, suggesting estrogen is a potent
mediator of liver health and metabolism. In the last funding cycle, we showed that female mice display enhanced
MitoFX compared to males, which likely underlies their protection against steatosis. In female mice, we have
demonstrated that ovariectomy (OVX-eliminates estrogen and ovarian function) dramatically reduces MitoFX,
while exercising (partially) and estradiol (fully) restores MitoFX. This data points to estrogen's role in regulating
hepatic MitoFX in female mice. Also, OVX in female mice provides a pre-clinical model system to investigate
mechanisms and develop therapies that can be used for female Veterans. Estrogen putatively mediates MitoFX
via estrogen receptor-a (ERa) signaling, a signaling node that is likely critical for estrogen replacement therapy.
A significant knowledge gap exists on how to positively modulate hepatic MitoFX and lower the risk for steatosis
after the loss of ovarian function, which is the focus of this proposal. We posit that a primary tool by which
exercise drives enhanced MitoFX is through the activation of mitochondrial quality control (MitoQC) mechanisms
after each bout, including an induction of mitochondrial dynamics (fission/fusion) followed by mitophagy. These
processes remodel or eliminate mitochondria with high oxidative stress or impaired coupling of oxidative
phosphorylation, resulting in curated pools of healthy hepatic mitochondria (coupled respiration, low oxidative
stress, and enhanced oxidative capacity). However, our preliminary data suggests that OVX impairs the ability
of exercise to activate hepatic MitoQC, which we believe will limit the power of exercise to improve MitoFX and
treat steatosis. This aligns with clinical data suggesting that exercise is less effective at treating steatosis in post-
menopausal women. In this proposal, we will test if exercise and estrogen signaling through ERa are critical for
exercise-induced activation of MitoQC and treatment of steatosis and liver injury after OVX. We will also test
whether estrogen and exercise require the activation of dynamin-related protein 1 (Drp1). Drp1 is a primary
regulator of mitochondrial fission and the initiation of MitoQC. We have recently shown that it is highly
upregulated in the liver after acute exercise in mice with normal ovarian function but is downregulated by OVX.
The role of Drp1 in mediating exercise and estrogen-induced effects on MitoFX is unknown. Therefore, we will
also test the hypothesis that estrogen and exercise require Drp1-mediated MitoQC to improve MitoFX and treat
steatosis and liver injury. To perform these studies, we will utilize the OVX model in female mice with or without
estradiol replacement combined with inducible molecular mouse models (liver specific-ERα knockout mice
(LERKO) and Drp1 mice (L-Drp1)) and novel outcome measures (mitochondrial-proteomics and high-resolution
respiration). These studies will explore underlying mechanisms by which exercise and estrogen mediate hepatic
steatosis through hepatic MitoFX. Mechanistic outcomes will inform the development of therapies and treatment
for hepatic steatosis in post-menopausal women, a portion of the VA population growing rapidly and at high risk
for metabolic and liver disease.

Public health relevance
Project Narrative Hepatic steatosis drives risk for liver disease (steatohepatitis and cirrhosis), type 2 diabetes, and cardiovascular risk. Hepatic steatosis diagnosis rates have increased by 17-fold from 2000 to 2017 in Veterans. Women represent 9% of the Veteran population but will increase to ~15% by 2040. Pre-menopausal women are protected against steatosis but have a much higher risk than men after menopause. Hepatic steatosis is and will continue to be a significant healthcare burden for female VA patients as they enter menopause. Using molecular approaches and mouse models, this proposal will examine mechanistic interactions between liver estrogen signaling, exercise, and mitochondrial quality control mechanisms after the loss of ovarian function due to ovariectomies. The underlying goal is to investigate therapeutic targets and provide mechanistic information for the role of estrogen hormone replacement therapy and exercise in modulating liver metabolism.